Core B: Community Outreach and Translation Core

The UCSF PEEC Formative Center is advancing scientific knowledge about how prenatal exposure to environmental chemicals can affect human development and reproduction. While continuing research will help clarify the relationship between these early exposures and child health and development, it is essential to communicate and act on what we know now to give children the head start they need to flourish throughout life. Accordingly, our Community Outreach and Translation Core (COTC) will translate and disseminate the personal, population and policy implications of preconception and fetal exposure to chemicals on human development The COTC will collaborate with the UCSF From Advancing Science to Ensuring Prevention (FASTEP) Alliance, an innovative and diverse alliance of newly engaged partners from academics, clinical care, and community based groups spanning the fields of reproductive, environmental, occupational, and pediatric health, and toxicology. FASTEP has the capacity to connect, educate and mobilize networks of reproductive and pediatric health physicians, nurses, midwives, and other clinicians, and their patients, health effected populations, consumers, workers and others impacted by the lifecycle of reproductive and developmental toxicants. The COTC will: (1) communicate the meaning of the PEEC Center's research to study participants and broadly, using innovative technology (e.g. web based and server based tools), written materials, and face-to-face meetings, to nurture communication, facilitate collaboration, and catalyze successful transmit our research into the clinic and community; (2) create and disseminate a science-based foundation for clinical care and policy change endorsed by key leaders; (3) sustain and expand a collaborative network of partners; and (4) advance public policy in the field of reproductive environmental health. The COTC will value and Integrate the diversity of knowledge, experience and perspectives held among the PEEC Formative Center's established and upcoming scientists, their research and clinical partner networks, study participants, and community partner networks in order to turn quality science about the impacts of the environment on children's health into timely prevention-oriented action.

Public health relevance
Transform the emerging scientific discoveries about the impacts of the environment on developmental and reproductive health into healthy pregnancies, children and future generations, through education and mobilization of diverse community and professional partners to promote and support prevention of harmful developmental exposures.